Be Curious, Not Judgmental: The 4th National Symposium on Sexual Behavior of Youth

Project Summary / Abstract
As the recognition of the prevalence and impact of problematic and harmful sexual behavior
(PHSB) of youth grows, so has the scientific endeavors to address the topic with findings
supporting efficacious early interventions (Borduin et al., 2021; St. Amand et al., 2008), child
sexual abuse prevention programs (Assini-Meytin et al., 2020; Letourneau et al., 2021; Shields
et al., 2020), and policy change (Kelley et al., 2019). Unfortunately, prevalent myths related to
understanding PHSB hinder effective prevention and response. To address these myths and
enhance scientist-practitioner partnership, this proposal is designed to meet the following
scientific, diversity, and educational aims within the 4th National Symposium on Sexual
Behavior of Youth: Be Curious, Not Judgmental to be held at Embassy Suites by Hilton Hotel
and Conference Center, Norman, OK. February 25-27, 2025. The meeting provides a forum for
1) lead researchers and experts in the field of sexual behavior of youth to share latest
outcomes, 2) dissemination of research and resources to promote culturally responsive care
and reduce disparities, 3) collegial, highly interactive opportunities for students and postdoctoral
fellows to present their research and enhance their communication skills through oral and poster
presentations, and 4) networking and mentorship to promote professional and career
development of women and underrepresented professionals. NSSBY is unique, as no other
national conference provides comprehensive coverage of sexual behavior of youth and at the
same time retains the openness and promotion of close interactions among participants
characteristic of a medium-sized conference. The confirmed speakers represent several of the
leading experts in their fields and are associated with many of the prominent research and
academic institutions from around the world. The agenda will include six daylong seminars, 36
concurrent workshops, welcome plenary, the Dr. Mark Chaffin Research luncheon, three
breakfast networking meetings, poster session and welcoming reception. To heighten
participant voice, the agenda will also feature plenary level panels from our Youth Partnership
Board and Caregiver Partnership Board members. The meeting will target approximately 325-
400 attendees from academia, government, and private agencies. The grant funds will support
scholarships for students (11) and underrepresented professionals (7) with hotel support awards
that will be granted to participants based on scientific merit.

Public health relevance
Project Narrative The National Symposium on Sexual Behavior of Youth’s three-day conference meets scientific, diversity, and educational aims addressing research on sexual behavior of youth. This grant facilitates access through scholarships for students and underrepresented professionals.